Joint Estimate Diffusion Imaging (JEDI) for improved Tissue Characterization and Neural Connectivity in Aging and Alzheimer's Disease

Alzheimer's Disease (AD) and related dementias (ADRD) are characterized by progressive structural
changes of brain tissue that results in a debilitating loss of cognitive and functional abilities and has profound
social and economic implications. While hallmark AD pathology (e.g. beta amyloid depositions and
neuroﬁbrillary tangles) are remarkably pronounced at the cellular level, there are currently no successful non-
invasive brain imaging techniques to report these microstructural changes.
Diffusion magnetic resonance imaging (dMRI) is a widely available non-invasive clinical imaging method
with this potential, as it is sensitive to the subtle motion of water within the complex brain gray matter (GM) and
white matter (WM) tissue architecture. In principle, dMRI can report both the local tissue structure and the long
range connectivity of neural tracts in order to identify pathology and determine the effects of AD on functional
brain networks. Unfortunately, the clinical utility of the standard dMRI methodology is severely compromised by
its lack of speciﬁcity to microstructural tissue changes below the image resolution.
Recently, however, we have developed a novel acquisition and analysis method called Joint Estimation
Diffusion Imaging (JEDI) that is highly sensitive to microstructural features of GM and GM/WM border regions,
and also provides improved connectivity maps from WM. JEDI is easily implemented on a clinical scanner and
we have recently incorporated it into a ﬁrst study on subjects ranging from cognitively normal (CN) to Mild
Cognitive Impairment (MCI) to early AD in order to assess its ability to detect changes in these groups.
Two critical steps in extending the clinical utility of JEDI in AD are: 1) To characterize the relationship
between the JEDI data and speciﬁc tissue microstructural features in order to develop quantitative clinical
metrics and 2) To develop efﬁcient acquisition protocols for both microstructural sensitivity and limited patient
scan time. That is the focus of this proposal, which will involve three lines of work: 1) Numerical computer
simulations of the JEDI experiment in realistic tissue models that will allow us to efﬁciently optimize the
acquisition protocol for maximum speciﬁcity and minimal time; 2) Validate these optimizations through in-vivo
evaluation of normal aging processes in the ferret and in ex-vivo radiologic-pathologic analysis in post-mortem
human tissue from patients with different stages of AD; 3) Incorporate these optimizations into the JEDI
acquisition and analysis of human protocols on our clinical scanners with speciﬁc application to examining the
prodromal microstructure tissue changes across the aging-MCI-AD continuum.
By enabling a reliable, validated and clinically viable method for the quantitative characterization of subtle
brain tissue changes across the aging-MCI-AD continuum, JEDI will signiﬁcantly enhance our ability to
understand the earliest neurodegenerative features of AD and provide new insights into its causes,
consequences, and possible treatment targets.

Public health relevance
PROJECT NARRATIVE Diffusion magnetic resonance imaging (dMRI) has a unique ability to non-invasively characterize microstructure and long range connectivity in brain tissues with coherent organization, such as white matter (WM), but has been less effective in more complex tissues that lack such coherency, such as gray matter (GM). This has limited its potential in detection and characterization of widespread but often subtle brain GM and WM changes associated with Alzheimer's disease and its related dementias (ADRD), Our proposal will optimize and validate a novel extension of dMRI that can simultaneously assess both GM and WM microstructure and connectivity in order to translate it into a new practical clinical imaging method for improved detection of Alzheimer's disease-related microstructural abnormalities.